Metabolic Landscape and Mitochondrial ROS Balance in Brain Ischemia/Reperfusion

Project Summary
Ischemia-reperfusion (IR) injury after perinatal asphyxia causes neurological disability,
morbidity, and even death in infants. To develop therapeutic strategies, we need a better
mechanistic understanding of the metabolic changes in cerebral tissue during IR and IR-driven
oxidative stress. IR-associated disruptions in glycolysis, the TCA cycle, amino acid and
nucleotide metabolism, oxidative phosphorylation, and reactive oxygen species (ROS) balance
lead to oxidative stress and contribute to cerebral tissue injury. The initial acute injury occurs via
ROS elevation whose origin is not yet completely known. Recently, we found that oxygen
deprivation in the brain results in so-called reverse electron transfer in mitochondrial Complex I
leading to high ROS production and dissociation of its natural cofactor, flavin (FMN). The
oxygen deprivation also degrades amino acids and purine nucleotides, which causes
accumulation of ammonia. Ammonia increases ROS generation by dihydrolipoamide
dehydrogenase (DLD), a component of ketoacids dehydrogenases of Krebs cycle. This
contributes to a cell-type specific increase of ROS during reoxygenation and redox imbalance.
Our preliminary results prompt further study of this metabolic pathway in the brain IR.
Our overarching objective is to determine the main contributors to redox balance of ROS
during brain IR. We hypothesize that ROS imbalance in brain IR is tissue-specific and involves
at least two metabolic mechanisms: 1) a ROS decrease due to mitochondrial FMN release, and
2) a ROS increase due to ammonia-dependent activation of TCA cycle DLD. We will use
advanced mass spectrometry imaging to determine the spatial distribution of small molecules in
brain sections obtained after IR for simultaneous visualization of various metabolites (Aim 1). In
Aim 2 we will establish the role of succinate and glycerol 3-phosphate-induced RET as
modulators of ROS production in brain using transgenic mouse model expressing alternative
oxidase. Mitochondria from these mice do not catalyze RET and do not produce ROS at the CxI
level. In Aim 3 we will evaluate the relative contribution of neurons and astrocytes to ammonia
accumulation and ROS balance. We will use freshly isolated, primary cultures of neurons and
astrocytes to analyze their ammonia-generating capabilities in response to lack of oxygen
These new, unrecognized, and unexplored mechanisms for the regulation of ROS production
in IR explain published observations showing the transient peak of ROS during brain IR.
Knowledge of the molecular details and regulation of mitochondrial ROS production is vital to
clarify the fundamental principles behind brain IR injury.

Public health relevance
Project Narrative Perinatal hypoxic-ischemic (HI) brain injury causes long-term neurological disability, morbidity, and death in infants. Using neonatal mouse models, we will uncover the mechanisms of redox imbalance in the brain that leads to oxidative stress after the oxygen deprivation/reperfusion associated with HI injury. Our line of research will pursue two recently identified metabolic pathways that may help to prevent, rather than just mitigate the damage, and to protect the infant’s brain from HI injury.